Epigenetic mechanisms and genes that regulate adipose tissue expansion

DESCRIPTION (provided by applicant): The global obesity epidemic is caused by multifactorial interactions between inherited allelic variation and the environment. Other components of obesity, based on variations in epigenetic programming, have been established by human epidemiological and animal studies that link nutritional status in utero and during early post-natal growth to the development of obesity and diabetes in adults. However, the mechanisms associated with these epigenetic contributions to obesity are not well understood. To identify epigenetic determinants of obesity, global analyses of gene expression was used to identify gene targets that are associated with phenotypic variations in the development of diet-induced obesity in a genetically identical population of mice. These analyses identified a set of genes that included imprinted developmental genes, antagonists of Wnt signaling and genes of angiogenesis and vascularization. Two of these genes, mesoderm specific transcript (Mest); a maternally imprinted gene localized in the endoplasmic reticulum/Golgi apparatus where it may function as a lipase or acyltransferase based on homology with members of the 1/2 hydrolase superfamily; and, bone morphogenetic protein 3 (Bmp3), an antagonist of bone formation that may act as an agonist of adiposity, are highly and coordinately expressed when fat mass is rapidly expanding. Mest and Bmp3 expression was shown to be elevated in adipose tissue biopsies of juvenile mice destined to develop diet-induced obesity as adults suggesting that molecular changes regulating these genes have been established prior to feeding a high fat diet. The coordinated expression and positive association of Mest and Bmp3 with variations of fat mass expansion in genetically identical mice suggests that epigenetic mechanisms are involved in their regulation. The studies in this proposal will determine the functional role for Mest and Bmp3 in fat mass expansion by using mouse models (Aim 1) and primary cell lines (Aim 2) with adipose tissue specific deletions for both genes; and, to uncover epigenetic mechanisms that regulate Mest and Bmp3 (Aim 3) by identifying changes in chromatin structure that are associated with their variable expression in adipose tissue of inbred mice. Understanding the mechanisms that regulate Mest and Bmp3 and how these genes control fat mass expansion could identify novel therapeutic targets for the treatment of obesity.

Public health relevance
Scientists have shown that many factors such as genetics and the environment interact to determine a person's susceptibility to developing diseases such as obesity and diabetes; however, very little is known about the molecular pathways that are involved in these interactions. Therefore, we studied a mouse model in where all of the individuals are genetically identical to study the basis for these alterations, and have identified several genes that are associated with variations in obesity. We propose to study how two of these genes, mesoderm specific transcript and bone morphogenetic protein 3, function in order to determine whether they could be used as drug targets for the treatment of obesity.